Mechanistic diversity in biased angiotensin receptor ligands

SUMMARY OF WORK
Many of the leading drugs for cardiovascular disease target G protein-coupled receptors (GPCRs). For example,
angiotensin receptor blockers (ARBs), which are antagonists of the angiotensin II type 1 receptor (AT1R), are
frontline therapeutics for hypertension. In recent decades, it has become clear that certain “biased” GPCR
ligands can preferentially activate subsets of the various cellular signaling pathways that are initiated by GPCRs.
For example, AT1R ligands may be biased towards signaling either through heterotrimeric Gq proteins or
b-arrestins. The ability to rationally design biased ligands could revolutionize GPCR drug discovery, but our
INCOMPLETE UNDERSTANDING of the mechanisms of these ligands has been a CRITICAL BARRIER to such
efforts. Our recent data have unexpectedly revealed that biased ligands from the same pharmacological class
can use distinct molecular mechanisms to activate AT1R. Our CENTRAL HYPOTHESIS is that these
mechanistic differences among ligands will lead to unanticipated functional differences in their signaling. To test
this hypothesis, we will employ interdisciplinary methods to understand the mechanisms of two classes of biased
AT1R ligands at the structural, cellular, and systems levels. Specifically, our AIMS are: (1) To determine the
functional consequences of mechanistic diversity in “b-arrestin-biased” AT1R ligands; (2) To elucidate the
molecular mechanisms of “dualsteric” (bitopic) AT1R ligands; (3) To develop biased dualsteric ligands for
endogenous AT1R. The IMPACT of this work is that it could guide the development of AT1R ligands tailored for
the treatment of various cardiovascular diseases, as well as the design of safer and more effective drugs
targeting other members of the conserved GPCR family.

Public health relevance
PROJECT NARRATIVE The angiotensin receptor controls blood pressure and is the target of angiotensin receptor blockers (ARBs), which are frontline medications for high blood pressure (hypertension). In this proposal, we will work to understand how we can change angiotensin receptor drugs to tune their effects. Ultimately this work could (1) enable the development of angiotensin receptor drugs for other cardiovascular diseases and (2) guide the development of safer and more effective drugs for many other related receptors.